Modulation of Endoplasmic Reticulum Associated Degradation to Support Ex Vivo Expansion of Hematopoietic Stem Cells

Abstract
Long-term hematopoietic stem cells (LT-HSCs) extensively self-renew to maintain the pool of HSCs for a lifelong
blood production and differentiate to generate all mature blood cells. Self-renewing LT-HSCs regenerate the
adult blood systems after transplantation, which is a curative therapy for many diseases, including
immunodeficiencies and leukemias. In addition, gene therapies with engineered HSCs are adopted as curative
therapies for an increasing number of diseases, such as sickle cell disease, hemoglobinopathies, autoimmunity,
and inheritable genetic disorders. Enhancing the efficiency of HSC ex vivo expansion and preserving HSC
reconstitution capacity after ex vivo expansion has broad therapeutic implications. However, in vitro culture of
LT-HSC has been limited by a loss of functional stem cells over time. This functional decline is at least partially
due to the dysregulation of proteostasis in cultured HSCs. There is growing evidence that dysregulated protein
homeostasis is associated with HSC exhaustion in ex vivo culture. Endoplasmic reticulum associated
degradation (ERAD) is a critical component of protein homeostasis, to ensure protein quality control by degrading
inappropriately folded or assembled proteins in ER. ERAD complexes recognize misfolded secretory and
membrane proteins in ER and dislocate them to cytosol for proteasomal degradation. Our recent studies show
that ERAD genes are enriched in quiescent and metabolically inactive HSCs as compared to proliferative and
activated HSCs. Furthermore, ERAD deficiency via knockout of Sel1L, an important component of the
Sel1L/Hrd1 ERAD complex, leads to hyperproliferation of HSCs that results in loss of HSC reconstituting capacity
and depletion of HSCs. Importantly, we observed decreased Se1L expression and accumulation of the ERAD
substrate after HSC culture, suggesting ERAD activity is decreased in cultured HSC. ERAD deficiency via Sel1L
knockout leads to a decrease of the number of HSCs after in vitro culturing and enhancing ERAD via
overexpression of Sel1L increased HSC expansion after ex vivo culture, supporting the hypothesis that ERAD
promotes HSC ex vivo expansion. To identify small molecular compounds that activate ERAD activity, we have
designed and optimized high throughput cell-based screening system using an ERAD activity reporter and
preliminary screening of the FDA repurposing library resulted in 4 chemicals that increase ERAD activity. All 4
compounds are HSP90 inhibitors, some of which have been previously shown to enhance HSC ex vivo
expansion, providing evidence that enhancing ERAD may promote HSC ex vivo expansion. Here we propose
studies to identify modulators of ERAD activity via a novel small molecular compound library and test the
hypothesis that loss of ERAD activity is associated with the loss of functional HSC in ex vivo culture systems
and that restoring ERAD function will improve HSC maintenance in culture and function following transplantation.
Our long-term goal is to improve culture methods for the clinical utilization of HSC in cellular and targeted gene
therapies.

Public health relevance
PROJECT NARRATIVE Gene therapy for many blood diseases requires growing blood stem cells in cultures and introducing genes to correct the genetic defects of blood cells. Expanding and modifying blood stem cells in cultured condition is associated with poor quality of proteins which leads to loss of stem cell functions. Our studies will identify and test new small molecular compounds to improve protein quality to preserve blood stem cell function after culture which has the potential to improve the efficiency of gene therapies.